2023 Glycobiology GRC and GRS

This is an application for partial support of the Glycobiology Gordon Research Conference (GRC) and the
associated Gordon Research Seminar (GRS) to be held together at the Four Points Sheraton in Ventura, CA, on
March 11-17, 2023. The Glycobiology GRC is one of the most prestigious forums in the field with a long-standing
tradition of very successful biennial meetings that have been regularly hold for past 44 years (the 2021
Glycobiology GRC was cancelled because of the pandemic). The 2023 conference, subtitled “From structure to
function: Biological roles of glycans as major building blocks of life”, will continue the tradition of emphasis on
the structure, function, and biology of macromolecular glycoconjugates. The breadth of topics and the diversity
of techniques employed in this highly multidisciplinary field will attract a diverse group of scientists with a
common interest in glycans and their functions. Oral sessions will focus on the glycobiology of cell communities,
cell signaling and molecular recognition, the immune and the nervous system, embryonic development, viruses,
pathogen-host interactions, glycoprotein biosynthesis and trafficking, human diseases, while also discussing
bioinformatic approaches and novel technologies in the field. Poster sessions will be held each of the four full
days in the late afternoon, and will continue informally after the evening sessions. Unique features of this
conference include: (i) a 5-10-minute discussion following each oral presentation, (ii) the secluded meeting
venue where all participants dine and socialize together outside of the sessions, (iii) afternoon social activities
planned to promote networking, and (iv) poster displays accessible throughout the day and following evening
sessions to maximize exposure. Short oral presentations will be selected from outstanding poster abstracts to
bring forth the latest developments in the field. Top graduate student, postdoc, and very junior faculty poster
presentations will be judged and awarded in the main meeting session. The Glycobiology GRS pre-meeting will
focus on graduate student and postdoc presentations, and a mentoring session, to provide young investigators
with opportunities for training and networking. All applicants will be encouraged to present a poster and special
efforts will be made to increase diversity, including participation of junior scientists, women, and minorities.
Special efforts to increase diversity will be enhance the impact on mentoring and training opportunities. The
logistics also focuses on enhancing publicity, accommodating the needs of attendees with children and families,
and handicapped individuals, who will be considered equally in the selection process. The meeting is expected
to bring together the leading and promising junior scientists in the field from all over the world and significantly
contribute to the generation and dissemination of novel ideas and technologies, promoting new collaborations,
and nurturing new generation of researchers from diverse backgrounds at the frontiers of biomedical research.

Public health relevance
Numerous studies have unveiled important roles of glycans in a wide range of essential biological processes and in various pathologies, such as cancer, metabolic abnormalities, various infections, and congenital diseases. The scientific discussions, research presentations, and informal interactions between the participants during the 2023 Glycobiology GRC and in the associated GRS will significantly contribute to advancing our understanding of these roles in human health and disease and will generate novel ideas for translational research and innovative therapies. Importantly, the GRC/GRS will provide unique training, networking, and mentoring opportunities for graduate students, postdocs, and junior investigators, including underrepresented minorities, which will nurture and invigorate the next generation of investigators in the field.